I. Institutional Career Development Core

Contact PD/PI: IMPERATO-MCGINLEY, JULIANNE L Inst-Career-Dev-001 (321)
I. INSTITUTIONAL CAREER DEVELOPMENT CORE (KL2)
PROJECT SUMMARY/ABSTRACT
The mission of the Institutional Career Development Core (KL2) is to train, mentor, and develop the next
generation of skilled, independent and diverse researchers to conduct high-quality clinical and translational
research and prepare them to meet the challenges of the current and future complex investigative environment.
The KL2 Program has established a track record of providing training for new and emerging technologies (e.g.
Nanotechnology, Bioengineering, and Biomedical 3D Printing) in addition to core competency training. Our KL2
graduates have made groundbreaking contributions to the field, and numerous KL2 professional development
initiatives have been introduced to inspire innovative research moving forward, include Advanced Certificate in
Clinical/Translational (C/T) Investigation and the; a Master’s Program in Clinical and Translational Investigation
The Entrepreneurs in Residence Program, where successful entrepreneurs serve as mentors to Scholars and
students; the CRESS program, consisting of seminars given by Alumni who discuss their path to success in
research and academia, industry, or government; and the Career and Professional Development Workshop.
Additionally, the CTSC Health Hackathon was created to cultivate our Scholars’ creativity with a focus on cross-
disciplinary teamwork that will stimulate the development of transformative advances in medicine. Great care is
taken to ensure that Scholars are matched with highly skilled and trained mentors who are dedicated to nurturing
the next generation of healthcare leaders. Mentored Grant writing programs are also provided to help KL2
Scholars and other researchers obtain funded research proposals. Moreover, Scholars can get research support
from National Research Support Services and CTSC Research Support Services as needed.
Diversity, equity, and inclusion will be prioritized and integrated into every aspect of the education program's
operations, with a focus on increased recruitment and retention of underrepresented groups. With newly
expanded initiatives involving creativity, entrepreneurship, team science, precision medicine, informatics, and
diversity, a highly skilled cadre of Scholars will be equipped to tackle the complex biomedical challenges with
innovative and impactful solutions to accelerate the clinical and translational continuum. In the proposed funding
period, the Program will leverage the strengths of Weill Cornell CTSC, its partners, its resources, and other active
collaborators to enable basic and clinical Investigators to achieve successful independence and make significant
contributions to the field of Clinical and Translational research. The successful programs will be made available
throughout the CTSC network. The planned duration of appointments, is two years, with an optional year if
necessary, (e.g. surgeons at 50% time) to three years and their projected number of scholars is (8) and includes
early to mid-career, postdoctoral, faculty.